SBIR TOPIC 411 "IMAGEDEPHI: IMAGE DE-IDENTIFICATION FOR THE ACCELERATION OF CANCER RESEARCH"

The objective of this project is to produce software that can de-identify and anonymize WSI and CT data in a reliable,
efficient manner. The end result will be a software product that can be used by the pathology and medical research
community to share data while minimizing the risk of exposing PHI/PII.